CHILDREN AT RISK FOR HYPERLIPIDEMIA

The safety and efficacy of dietary and medical treatment of children with familial dyslipoproteinemia are being evaluated. Nicotinic acid (Niacin) has recently been added for certain children who require 4-6 week check-ups in early stages of therapy. The relationship between insulin resistance and small dense HDL-cholesterol is also being investigated.